The role of differential bone marrow immune landscape in permissive tumor growth in the spine

PROJECT SUMMARY/ABSTRACT
Roughly 400,000 people in the U.S. have bone metastases, the vast majority occurring in the spine.
Metastases to the spine results in fractures, pain, paralysis, and enormous health care costs. This pathological
process is not fully understood. Immune cells are an important constituent of the bone marrow
microenvironment and have been shown to play a significant role in tumor growth and progression in soft
tissue disease specifically myeloid cells. Additionally, immune cell composition within the bone marrow
microenvironment may vary by location, further contributing to immune escape of cancer cells and variable
rates of metastases. The role of the immune microenvironment in bone marrow and the differential expression
of myeloid cells in different bones has not been extensively investigated. We have preliminarily examined the
immune microenvironments in different bone regions and observed differences in the immune cell populations
between the spine and the femur. Based on previous research in soft tissue tumor progression and our novel
preliminary data, we will further investigate these differences in local bone immune environments to glean
knowledge that can be translated into targeted therapies that limit or prevent metastases to the spine. We
therefore hypothesize that there is an immunosuppressive signature, driven by changes in the myeloid
population, in the vertebral bodies compared to the long bones and that in the setting of cancer, this signature
is enhanced. Our approach utilizes high-fidelity, high-throughput technology in the form of time-of-flight mass
spectrometry (CyTOF) and single-cell RNA-seq (scRNA-seq) to globally interrogate cell populations in the
context of a particularly heterogeneous background to construct insights into the oncogenic signaling pathways
linking immune cells to the tumor-promoting phenotype within the bone marrow niche. To test our hypothesis,
we propose the following two specific aims: 1) Characterize the differences in the native and premetastatic
immune cell landscapes between the vertebrae and long bone. 2) Determine the functional significance
of immune population differences between vertebrae and long bones on tumor initiation and
permissive growth to spine. The applicant assembled a mentorship committee of high quality and specific
specialties available at the University of Michigan. This strong mentorship committee, training environment,
and research proposal will provide the necessary resources to successfully complete this proposed project.
Results from this proposal will advance our understanding of bone metastases and bone immunology and
facilitate the identification of unique highly specific targets that may be used in alternative therapies to improve
clinical outcomes for patients with spine metastases. Additionally, this project will foster for the applicant a new
skillset that can be used in this emerging field of osteoimmunology and metastatic disease. Ultimately, the
applicant will use this award to generate additional data for obtaining extramural funding and advancing his
career as a surgeon scientist in the field of spine oncology and osteoimmunology.

Public health relevance
PROJECT NARRATIVE Metastases to the spine causes significant undue morbidity and mortality as a result of fractures, immense pain, paralysis, and enormous health care costs for many cancer patients. This study will examine differences in the immune cells within the bone marrow of vertebral bodies and long bones, specifically determining if vertebral bodies contain an immunosuppressive microenvironment that promotes metastatic growth in patients with systemic cancer. The success of the studies outlined in this proposal will lead to improved understanding of the pathophysiology of initiation and progression of spine metastases in the setting of bone immunology and may lead to novel targeted therapies.